miRNAs and PPAR-gamma-induced neuroprotection

DESCRIPTION (provided by applicant): The miRNAs are transcribed as primary miRNAs (primiRs) by RNA polymerase II from either independent miRNA genes or from the introns of protein-coding genes. The miRNA gene promoters are known to contain many transcription factor binding sites, but the role of transcription factors in miRNA biogenesis is not yet understood. We made an in silico observation that the promoters of certain miRNAs contain binding sites for the transcription factor PPARγ known as PPREs. Preliminary studies showed that several miRNAs that contain PPREs in their promoters were induced by PPARγ agonist rosiglitazone indicating that PPARγ might control the expression of miRNAs. In addition to targeting 3'-UTRs of mRNAs to repress translation, the miRNAs can also bind to the promoters of protein-coding genes in a sequence-specific manner. With bioinformatics, we observed binding sites for 4 miRNAs in PPARγ promoter indicating that those miRNAs might control PPARγ gene expression. Interestingly, PPARγ promoter contains binding sites for miRNAs that have PPREs in their promoters. For example, promoters of mir-329 and miR-145 showed 4 PPREs each while PPARγ promoter showed binding site for both miR-329 and miR-145. We hypothesize that PPARγ and specific miRNAs modulate each other with significant consequences in maintaining cellular equilibrium. Furthermore, some of the pleiotropic neuroprotective effects of PPARγ agonists might be due to their effect on miRNAs. Aim 1 is to test if PPARγ activation alters the expression of PPRE-containing miRNAs and to study if PPARγ down-stream miRNAs play a role in PPAR-mediated neuroprotection. Aim 2 is to test if specific miRNAs can induce PPARγ expression by promoter interaction and if that can potentiate the neuroprotection afforded by PPARγ agonists. The overall goal is to study if PPARγ is in a cyclical loop with certain miRNA and their mutual inducibility has functional significance.

Public health relevance
Transcription factors and microRNAs are master controllers of gene and protein expression. This proposal wishes to evaluate the mutual interaction and the subsequent consequences of a transcription factor known as PPAR with certain miRNAs in mediating neuroprotection after ischemia.